Integrated analysis of HBV-specific CD4 T cell and B cell responses to define their role in chronic hepatitis B and HBV functional cure.

Project Summary
The overarching goal of this multi-PI R01 proposal is to identify the mediators of functional cure of hepatitis B
virus (HBV) infection in the cellular and humoral immune responses. Understanding the immune correlates of
HBV functional cure, but also the molecular pathways involved in the immune dysregulation leading to persistent
HBV infection and hepatitis will greatly facilitate design of effective immunotherapies and therapeutic
vaccinations. HBV chronically infects >250 million people and remains a significant public health burden, despite
the availability of an effective prophylactic vaccine for more than 30 years. While some infected individuals can
naturally control viral replication, known as functional cure, the required immune conditions, particularly in the
CD4 T cell and B cell responses, are undefined. Similarly, the exact mechanisms of how HBV-specific CD4 T
cell and B cell responses are subverted in persistent infection remains unclear. In this study, we will study the
immune responses of well-defined clinical cohorts across the different HBV infection outcomes. The two aims
are: (1) to define HBV-specific CD4 T cell functions and the molecular signatures important in immune
suppression versus cure; (2) to define HCV-specific humoral responses and the molecular signatures in B cells
associated with viral pathogenesis and cure. The two highly complementary and synergistic aims will be
analyzed in a highly integrated systems approach, allowing novel understanding of how CD4 T cells, antibodies
and B cells synergize in order to control HBV infection. By using the same tissue specimens from the clinical
cohorts for all we will achieve a holistic and integrated understanding of the immune landscapes presented in
the different manifestations caused by HBV infection. The results have the potential to guide novel
immunotherapeutic approaches aimed at inducing sustained control of HBV without the need for life-long antiviral
treatments.

Public health relevance
Project Narrative HBV chronically infects >250 million people and remains a significant public health burden, despite the availability of an effective prophylactic vaccine for more than 30 years. Immunological control of HBV, i.e. functional cure, is possible, as evidenced by HBV natural history in some infected populations, but the immune correlates of protection remain undefined. Here we will define the immune responses mediating functional cure and identify pathways of immune dysfunction that could be targeted by specific immunotherapies.